Open Software Platform for Data-Driven Image-Guided Robotic Interventions

Project Summary/Abstract
More than 232 million surgeries and interventions are performed each year worldwide, and 51.4 million in the
US. Despite improvements in surgical technology and techniques, complication rates of up to 20% are reported.
Image guidance is a key factor in improving surgical outcomes and reducing complications. While imaging is
routinely used for diagnosis and staging prior to surgery, the majority of the millions of surgical and interventional
cases are still performed without a direct link to pre-operative images, instead relying on the operating physician’s
decisions based on experience. Image-guided robotic interventions (IGRIs) are being investigated to address
those challenges. The underlying hypothesis is that the combined image-guidance and robot-assistance
enhance the physician’s ability to see and physically access the lesion with minimal invasion resulting in a better
clinical outcome. However, usage of image information in IGRI systems merely follow current conventional non-
robotic procedures; those robots are controlled simply based on the geometric information obtained from the
image, which leads to a discrepancy between the plan and the actual physical space in vivo due to various
uncertainties, including patient motion, heterogenous tissue properties, and communication latencies between
system components (e.g., sensors, robot hardware, and software). As a result, IGRI has not shown a clear
advantage over conventional non-robotic procedures in terms of clinical outcome. The growing number of IGRI
applications and the recognition of the real-world challenge led to a shift of research interest from a hardware-
centric approach, which pursues mechanical precision, to a “data-driven” approach, where the treatment is
modeled based on data obtained from imaging scanners, sensors, and medical records for personalized planning
and control for better clinical outcomes. The data-driven approach requires sizable engineering resources
because of the wide range of software components involved. Particularly, integration of software components
developed in different fields, i.e., robotics and medical image computing, is challenging due to the lack of robust
software platforms that are compatible with every component used. To address this challenge, we will integrate
popular medical image computing and robotics software packages, namely Robot Operating System version 2
(ROS2) and 3D Slicer into a single platform. This new platform, called SlicerROS, will be distributed as a plug-
in for 3D Slicer. SlicerROS will allow incorporating state-of-the-art robotics and medical image computing tools,
which are developed and validated in the robotics and medical image computing communities, into a single IGRI
system. We will work on the following aims: (Aim 1) Extend 3D Slicer/ROS integration to achieve seamless
integration of medial image computing and robotics tools for data-driven IGRI; (Aim 2) Disseminate SlicerROS
in the medical image computing and robotics communities to build an active user/developer community for
sustainable open-source software development and maintenance.

Public health relevance
Project Narrative The goal of this project is to develop and disseminate free, open-source software named SlicerROS to support advanced “data-driven” image-guided robot-assisted intervention (IGRI) systems, where patient-specific anatomical and physiological information extracted from medical images (e.g., CT, MRI, PET, ultrasound) is incorporated into planning, navigation, and controlling of robot-assisted surgery. SlicerROS will integrate popular open-source software packages, namely 3D Slicer and ROS, enabling developers to combine existing state-of- the-art medical image computing and robotics algorithms, which are developed in the research community, into a single system; hence it will speed up the development, testing, and bench-to-bedside translation of new data- driven IGRI technologies.